Does Ethnic Variation of the Orbit Determine the Prevalence of Horizontal Strabismus?

The prevalence of horizontal strabismus differs dramatically between studies for reasons that are not clear.
Our preliminary data show that ethnicity is a major factor: some populations have much more esotropia than
exotropia, while other populations have much more exotropia than esotropia. Older literature suggested that
differences in the interpupillary distance may be responsible for ethnic differences in strabismus, but this has
never been systematically explored. Because of the largely undefined ethnic variations, the global prevalence
of strabismus is currently unknown. Furthermore, the prevalence within the same ethnicity has never been
longitudinally compiled and compared. This lack of information about local and global prevalence makes it
impossible to determine trends and to compare them with trends of major risk factors and thus define
underlying causes or predispositions for strabismus. This impedes the planning of health care that will be
needed in the future. Here, we propose to solve these problems by conducting secondary data analyses.
Aim 1: Compile ALL relevant studies and publish a systematic review of the prevalence of horizontal
strabismus throughout the world, taking into account ethnic variations and methodology bias. This will
provide a much-needed reference guide and allow to estimate the true global prevalence.
Aim 2: Examine the distribution of three orbital parameters that are ethnically distinct: interpupillary distance,
proptosis, and interorbital width, and discern which parameters (or combination of parameters) best explains
the ethnic variation of horizontal strabismus prevalence and patterns. This will provide an evidence-based
framework to understand the current ethnic variations and their evolutionary history.
Aim 3: Determine the trends (over the last 50-150 years) in prevalence of horizontal strabismus and
compare them with local trends for major risk factors of strabismus. This will identify effective risk factors in
local populations – which is relevant for planning purposes and for targeted health care initiatives.
Our multidisciplinary team of investigators will move the field forward by establishing population-based
prevalence numbers for each of the major ethnicities. This is important to provide a comprehensive
reference work for future studies. The true prevalence in different countries and ethnicities is important for
health care planning purposes. The second aim will inform which key anatomical features of the orbit underlie
ethnic differences, with evolutionary, developmental and clinical implications. This will provide a novel
conceptual framework of the impact of orbital parameters for strabismus. Finally, consideration of a
much larger number of studies and populations throughout the world (~500 vs. ~30 in previous reviews) will
allow us to define trends in prevalence and to compare such trends with those of major risk factors of
strabismus within those same populations. This will inform which risk factors (e.g., maternal smoking,
Cesarean section) likely affect prevalence rates in distinct populations.

Public health relevance
This proposal addresses a priority area for the National Eye Institute, investigating the true prevalence of horizontal strabismus among different ethnicities, understanding how such ethnic diversity has evolved, and identifying which risk factors are relevant in different populations that impact on prevalence. This will fill three critical gaps of knowledge: (1) role of ethnicity in prevalence and type of horizontal strabismus, (2) a coherent framework to explain the role of the orbital anatomy for the expression of strabismus types, and (3) elucidating how trends among the major risk factors for strabismus affect trends of prevalence and strabismus types within local populations.